Administrative Core

Project Summary: Administrative Core
The LA CaTS Center Administrative Core has been set up to promote, support, and continually evolve the
governance and administrative structure of the Center, to effectively facilitate the necessary leadership, tools
and processes required to integrate and align the Cores of the Center and accomplish the mission of building
research infrastructure to address health outcomes in Louisiana. The leadership of the Administrative Core is
comprised of the LA CaTS Center Principal Investigator (Pennington Biomedical Research Center) and two
Program Co-Directors (LSUH-New Orleans and Tulane University), along with support and management staff at
the three administrative offices. The Administrative Core coordinates and streamlines business and management
functions across the network institutions with the goal of reducing barriers, obstacles, and helping to bridge
research gaps. The Core will work to maintain and further develop the culture of trust established between the
partners over the past two funding cycles; one that has been particularly conducive to fostering high levels of
collaboration between investigators and institutions both within and outside the state. The Core's activities will
also ensure effective two-way interaction with stakeholders and close collaboration with our community partners.
For the 3rd funding cycle, the Administrative Core will work with the Steering Committee and Operations
Committee to act on and provide resources to support and bring to fruition the scientific opportunities identified
in the Center's strategic plan. These opportunities include but are not limited to 1) facilitating “team science” and
clinical trial growth; 2) strategic faculty recruitment among LA CaTS Center institutions; 3) enhancing equity,
diversity, and inclusion (EDI) initiatives and training; 4) increasing community based participatory research; and
5) promoting precision medicine and nutrition initiatives. Importantly, the Center has secured substantial
resources and responsibilities related to COVID-19 research and so it is expected that a considerable amount
of time and effort will be devoted to monitoring, reporting, and building on the NIH funded research acquired in
Cycle 2 (e.g., RADx-UP, PASC/RECOVER). The Administrative Core will coordinate and offer the resources,
activities and initiatives that will support investigators in their goal to accomplish the overall LA CaTS Center
mission to “address health disparities and improve health outcomes” in Louisiana's most vulnerable and
underserved populations.